Cell Stress and Biophysical Therapies

The overarching themes in the Cell Stress and Biophysical Therapies (CSBT) Program are to understand
how stress response pathways influences malignant transformation of cells, and in turn, to understand the ability
of malignant cells to subvert and overcome the stress they endure during growth and metastasis, processes that
render them more resistant to cancer therapies. CSBT aims to reduce stress-induced malignant events and
rationally modulate stress response pathways to better treat and prevent the development of aggressive cancers
while protecting normal tissues and organs. Roswell Park is the only comprehensive cancer center in the nation
with a CCSG Program devoted to the study of stress, and while the concept of stress covers many areas, a
unifying strength of the CSBT Program is its efforts to understand diverse stresses in the framework of common
and fundamental molecular mechanisms associated with cancer progression and therapeutic response and
hence survivorship. CSBT Program research is organized in two Specific Aims, each of which is aligned with the
strategic plans of Roswell Park: 1) to identify and target intrinsic stress response mechanisms in malignant cells
and 2) to characterize the impact of physiological, environmental, and therapeutic stressors in the tumor bearing
host, both systemically and within the tumor microenvironment. CSBT works very closely with other Programs,
in particular DT, to translate these findings into the clinical arena.
The program is co-led by Elizabeth Repasky, PhD, a laboratory scientist with wide expertise in
translational research, and Anurag Singh, MD, a Radiation Oncologist, clinician- scientist who became a CSBT
Program Co-Leader in February 2018. Drs. Singh and Repasky have complementary expertise that covers a
broad swath of basic, translational and clinical applications of stress biology and oncology. The inherently
collaborative structure of the CSBT Program is exemplified by a longstanding Program Project Grant led by
Sandra Gollnick, PhD. The Program is comprised of 19 members (with 25 peer-reviewed projects) from 8
Roswell Park departments (Pharmacology & Therapeutics, Molecular & Cellular Biology, Cell Stress Biology,
Surgical Oncology, Dermatology, Pathology, Immunology and Radiation Medicine) whose NCI funding is $2.4M,
total peer-reviewed $2.7M, and total funding of $4.4M (project direct costs). The CSBT Program enjoys robust
basic science research enhanced by inter-and intra-programmatic, national, and international research
collaborations. Since the last review, NCI funding, peer-reviewed and total research support, has increased. Of
the 282 publications generated over the last funding cycle, 10% were intra-programmatic, 36% were inter-
programmatic collaborations and 81% inter-institutional, with 25 published in journals with an impact factor of 10
or greater. Training and mentoring opportunities for trainees and new investigators are provided within the CSBT
Program. The CSBT Program has benefited from use of Shared Resources and support from the CCSG and
Roswell Park. CSBT Program research is closely linked to cancers found in our catchment area.